OPEN ACCESS SPOKEN LANGUAGE DATA FOR UNDERSTANDING DEMENTIA

Abstract
We propose the expansion of the shared DementiaBank database of multimedia interactions for the study of
cognitive-communication impairments in aging and Alzheimer’s disease and related dementias. Our continued
work will rely on advances in data collection, transcription, analysis, sharing, and web delivery achieved in the
context of the overall TalkBank Project. We will deploy and extend the growing assets of TalkBank,
AphasiaBank, and DementiaBank to answer critical questions regarding the diagnosis, classification, and
longitudinal tracking of language in dementia. The overall goal of this work is to support the development of
cognitive-linguistic outcome measures and treatments that will improve the evaluation and effectiveness early
diagnosis and identifying those at-risk for dementia. To reach that goal, we must solidify data analysis and
training methods (i.e., collaborative commentary, automatic speech recognition, and machine learning
benchmarks). We will also focus on the expansion of dissemination methods to ensure the DementiaBank
tools and resources are meeting the needs of researchers and clinicians.

Public health relevance
We will deploy and extend the growing assets of TalkBank, AphasiaBank and DementiaBank to answer critical questions regarding the diagnosis, classification, and longitudinal tracking of language in dementia. We will use the newly developed Collaborative Commentary system to track high-level discourse features that have not been fully open to study through previous methods. We will use and refine our new automatic speech recognition (ASR) pipeline to create high quality transcripts from people with dementia for lexical, discourse, grammatical, phonological, and fluency analysis. We will use this new data to refine the methods for detection and progression tracking of dementia. Crucially, we will work with colleagues at other sites interested in deploying these methods clinically to grow the database.